Texas Center for Health Disparities (TCHD)

The long-term objective of the Texas Center for Health Disparities (TCHD) is to expand the capacity of University of North Texas Health Science Center (UNTHSC) to enhance research and research training in health disparities by increasing the number of faculty and students in health disparity research, providing interdisciplinary research and leadership training to junior faculty, and increasing the number of health professional faculty involved in health disparity research. Given the substantial need for physicians, physician scientists, and other health professionals to care for populations that experience health disparities, and the critical need to study diseases and conditions that disproportionately affect these groups, more efforts are needed to increase the participation of skilled individuals in conducting research on health disparities, and encouraging them to consider careers in research and related fields. The Texas Center for Health Disparities (TCHD), a NIMHD-Specialized Center of Excellence developed the proposed program, through the NIMHD S21 mechanism, to increase health disparity research capacity by increasing the size of the PhD workforce in health disparities, train junior faculty in interdisciplinary research leadership, and provide opportunities for senior investigators to develop research focus in health disparities. Four priority activities will be conducted under the TCHD program: Priority Activity 1: Develop an Interdisciplinary Research Leadership (IRL) Program for junior faculty in Health Disparities. Priority Activity 2: Establish a Health Education, Awareness and Research in Disparities Scholarship (HEARD Scholars) program for recruitment/retention of faculty in and Health Disparities education and research. Priority Activity 3: Increase the biomedical, behavioral and clinical research workforce by recruiting a new cohort of PhD students each year who focus on health disparities. Priority Activity 4: Develop a mechanism for health disparity researchers to engage community members in their research. Using the endowment funds secured through this mechanism of funding, we will ensure robust training opportunities are provided that encourage participants of the proposed program to seek careers in research and related field that address the issue of health disparities. The impact of the endowment income will be sustainable programs in Health Disparities, including health disparity curricula for PhD students, a junior faculty development program that can be expanded to faculty from other institutions, and a cadre of health disparity researchers who have active research projects in the area of Health Disparities.

Public health relevance
The goal of the Texas Center for Health Disparities (TCHD) program is to utilize the John Lewis NIMHD Endowment funding to build capacity and infrastructure at the UNTHSC for its nationally recognized health disparities research, training and outreach activities, specifically in recruiting and training faculty and PhD students. Through an innovative interdisciplinary research leaders’ program, a faculty scholarship program and training PhD students in health disparities, TCHD will enable transdisciplinary, interprofessional collaborations and novel approaches to understanding and eliminate health disparities.